Endoplasmic Reticulum Protein Homeostasis in Renal Physiology and Acute Kidney Injury

Acute kidney injury (AKI) is a life-threatening and costly condition, affecting ~15% of all hospitalized patients,
including up to 65% of those requiring intensive care. Despite the consequences and expense associated with
AKI, proactive fluid management and dialysis remain the only interventions. Yet, as AKI develops, cells initially
induce protective pathways to maintain their viability. One pathway, the Unfolded Protein Response (UPR), is
initiated in the endoplasmic reticulum (ER) and can protect cells from the accumulation of damaged proteins
and oxidative injury, preserving protein homeostasis (“proteostasis”) despite environmental stress. However,
as a result of unmitigated stress, ER stress and UPR activation are cytotoxic, and emerging data suggest that
the UPR may cause AKI. To directly link the UPR to AKI, and to ask if ER stress and the UPR are directly
associated with AKI, a unique inducible nephron-tubule-specific knockout (KO) mouse was created and
characterized. In this model, the gene encoding GRP170, a molecular chaperone that maintains ER
proteostasis, can be deleted at will. The applicant’s published data indicate that GRP170 ablation causes
inappropriate UPR activation and a severe AKI-like phenotype.
To more precisely define how the UPR contributes to AKI, the applicant has recently been focused on
heterozygous GRP170NT+/- mice, which have more subtle UPR activation but are susceptible to kidney injury
only when subjected to an additional renal stressor. Preliminary data indicate a temporal association between
stimulation of one UPR stress sensor, PERK, and early AKI, implying a causal link. Hence this GRP170NT+/-
model is the ideal tool with which to clarify the UPR-AKI relationship, avoiding interference from the
confounding variables that hindered prior in vivo studies. To this end, the first objective of this project is to
discern the mechanism by which PERK drives AKI caused via two clinically-relevant insults: a commonly used
nephrotoxic chemotherapeutic, cisplatin, and Ischemia-Reperfusion Injury (IRI). The second objective is to
determine if a preclinical PERK-specific inhibitor ameliorates AKI in vivo. Together, these two approaches will
clarify the role of PERK in AKI and inform development and/or repurposing of PERK-modulating drugs for AKI.
Enhanced experimental training will expand the applicant’s experience with diverse techniques and resources,
including murine and renal tubule epithelial cell culture AKI models, imaging, and transcriptomics. In addition to
technical competence, this award will further develop the applicant’s writing, presenting, mentoring, and
management skills. Training will be realized in the labs of well-established co-mentors with complementary
expertise and a history of educating successful trainees. Training will be enhanced by the exceptional
environment offered at the University of Pittsburgh. Formal coursework, participation in seminars, and
presentations at local and national meetings provide further avenues for professional development. Overall,
these experiences will enhance the applicant’s goal of becoming an independently funding NIH investigator.

Public health relevance
PROJECT NARRATIVE Acute kidney injury (AKI), the sudden loss of kidney function manifesting as the accumulation of fluid and metabolic waste and impaired electrolyte and acid-base regulation, is a common, costly, and potentially life- threatening condition for which there is no effective treatment. AKI causes cell death in the kidney by compromising a number of intracellular processes, including protein regulation. This project will, therefore, investigate the relationship between disruption of protein regulation and AKI with the goal of identifying key molecules that could be targeted by novel AKI pharmaceuticals.